The economic and social impact of COVID-19 mitigation and vaccination policies: Supplement for special issues & associated conferences

Project Summary
The project "The economic and social impact of COVID-19 mitigation and vaccination policies:
supplement to publish two special issues" will leverage the scholarly output from the funded R01
parent project (R01AG071649-01, Lillard PI). The activities funded by this supplement will be to
hold two conferences featuring articles from the parent project and to publish the papers from
those conferences in special issues at two journals. We have an agreement in place to publish
one special issue at the Journal of Labor Economics (during the period October 2025 to July
2026). The journal for the second special issue is yet to be determined.

Public health relevance
Project Narrative The project "The economic and social impact of COVID-19 mitigation and vaccination policies: supplement to publish two special issues" will leverage the scholarly output from the funded R01 parent project (R01AG071649-01, Lillard PI) by publishing two special issues and holding two conferences prior to the submission of the papers for each special issue.